Trajectories of Cortico-Cerebellar Connectivity, Social Competence, and Internalizing Symptoms in Adolescents Born Very Preterm

PROJECT SUMMARY: Children born very preterm (VPT, <32 weeks’ gestation) are at increased risk for social
competency impairments compared to their term-born peers, including social communication deficits and poorer
quality peer relationships leading to peer victimization and social rejection. Further, internalizing disorders are 2-
3 times higher in VPT children, with symptoms evident in early childhood and lasting into adulthood. Critically,
how social competence impairments evolve and persist into adolescence, and the extent that known risk factors
associated with VPT birth, including psychosocial adversity and executive dysfunction, shape their trajectory to
increase risk for internalizing disorders remains unknown. Additionally, the cerebellum is a key structure
adversely impacted by VPT birth, and aberrant cerebellar development is now recognized as a major risk factor
for social communication deficits. Altered cerebellar development, along with its functional interactions with the
Frontoparietal and Default Mode Networks involved in socio-emotional function, may be a key mechanism linking
VPT birth, social impairment, and internalizing disorders. We posit that individual-specific patterns of cortico-
cerebellar connectivity and related white matter tract (i.e., cerebellar peduncle) development underlie the
evolution of social competence deficits, and in turn, internalizing disorders that persist or worsen at age 14-15,
a critical period when peer interactions become more sophisticated and central. This process begins during
infancy and extends to adolescence, with psychosocial risk playing a pivotal modifying role. Advances in MRI
methodology now enable characterization of structural and functional brain networks with unparalleled spatial
and temporal resolution. We couple innovative MRI techniques with detailed social-interaction and psychiatric
assessments in a unique, longitudinal cohort of VPT and term-born adolescents (N=302; 137 VPT and 165 term-
born) with high rates of psychosocial adversity now aged 14-15 years. The cohort has been followed since birth,
undergoing prospective high-quality neonatal and school-age structural and functional connectivity MRI scans
and longitudinal assessments of social competence, socio-emotional functioning, and psychosocial and familial
risk at ages 2, 5, and 9-10 years (>80% retention at all waves). Continued evaluation of this valuable cohort
provides an unprecedented opportunity to determine: 1) trajectories of social competence and internalizing
symptoms for better identification of adolescents at greatest risk for psychopathology and 2) how trajectories of
cortico-cerebellar structural and functional connectivity underlie these deficits. State-of-the-art MRI acquisition
and analyses will characterize the deleterious effects of VPT birth on cortico-cerebellar connectivity into
adolescence. We will delineate links between cortico-cerebellar connectivity, social competence, and
internalizing disorders to elucidate modifiable psychosocial exposures and improve individual-level
neuroimaging, behavior, and psychosocial predictive models that inform the timing of preventative interventions
during sensitive periods of brain and socio-emotional development to mitigate risk for internalizing disorders.

Public health relevance
RELEVANCE TO PUBLIC HEALTH This study is designed to improve our understanding of the changes in brain structure and function that underlie the elevated rates of social impairments now increasingly recognized in prematurely-born children. Using cutting- edge magnetic resonance imaging methods, we will investigate these relationships in a unique, longitudinally- studied cohort of very preterm and term-born children with high rates of psychosocial adversity now reaching age 14-15 years and previously studied using advanced neuroimaging and detailed assessments of neurodevelopment and psychiatric symptoms across childhood. The overarching goal is the development of new approaches for earlier, more accurate identification of children at risk for social impairments, enabling progress toward targeted interventions which improve outcomes by limiting risks for psychopathology associated with prematurity and psychosocial adversity.